Mechanisms of Zic2 function in zebrafish.

PROJECT SUMMARY
Holoprosencephaly (HPE) is a congenital malformation of the cerebral cortex linked to genetic
disruption in Hedgehog (Hh) signaling. Hh signaling acts early in the developing forebrain (future
cerebral cortex) to control transcription of key target genes by zinc-finger transcription factors GLIs.
ZIC2, a transcription factor with homology to GLIs, is also linked to HPE. Our work in zebrafish
showed that ZIC2 homologs zic2a and zic2b pattern the forebrain by modulating Hh signaling, but the
mechanism of this regulatory relationship is poorly understood. Recently, Zic2 and Glis were shown to
function as co-factors of the nucleosome remodeling and histone deacetylase complex (NuRD) in
mammalian embryonic stem cells. Our preliminary evidence shows that zic2a and hdac1 interact
genetically in zebrafish. These data have led us to hypothesize that Zic2 regulates the transcriptional
readout of Hh signaling in the forebrain primordium through regulation of chromatin dynamics. To test
this hypothesis, we will ask if Zic2 controls Hh target gene transcription by modulating histone
dynamics and if it physically interacts with NuRD in the zebrafish forebrain. We have designed an
innovative strategy that combines in vivo genomics and proteomics with unique transgenic zebrafish
lines to answer these questions at the stage of development when the forebrain is most vulnerable to
disruptions that result in HPE. Aim 1: Identify candidate Zic2 targets in the developing forebrain
using CUT&RUN and RNAseq. No direct transcriptional targets of zic2 in the developing forebrain
have been identified to date. We will use CUT&RUN, recently optimized for use in zebrafish, to map
DNA binding sites of Zic2a, and to ask if zic2 function regulates chromatin remodeling and
transcription of Hh target genes. To do this efficiently, we will adapt a CUT&RUN modification which
relies on transgenic GFP-tagged Zic2a and a GFP nanobody fused to a micrococcal nuclease. Aim 2:
Identify protein partners of Zic2a using in vivo proximity labeling. A role for Zic2 in regulating
chromatin dynamics, suggested by recent findings in mammals, has not been tested in the context of
the embryonic forebrain. We will use proximity-directed biotinylation and mass spectrometry to identify
in vivo binding partners of Zic2a in the zebrafish embryo. Completion of these aims will shed light on
an important, poorly understood regulatory relationship between Hh signaling and Zic2 in the
developing vertebrate forebrain, removing a critical barrier toward deciphering the genetic basis of
HPE.

Public health relevance
NARRATIVE The proposed research is relevant to human health because it targets a poorly understood genetic mechanism that underlies holoprosencephaly, a congenital cerebral malformation in humans. Holoprosencephaly results from a developmental error that happens very early during human embryogenesis, approximately 4 weeks post- conception. Since genetic mechanisms that control cerebral development are conserved across vertebrates, we will take advantage of the ex vivo development and sophisticated experimental tools available in zebrafish to identify new genetic and epigenetic risk factors for holoprosencephaly in humans. .